tRNA modification reprogramming and translational remodeling in cancer

Project summary
Over 300 different chemical modifications on RNA have been identified and this ‘epitranscriptome’ plays
important roles in the posttranscriptional control of gene expression. Dysregulation of certain RNA-modifying
enzymes including RNA methyltransferases (MTases) is linked to cancer initiation and progression, and new
evidence suggests these may provide a new class of druggable targets for treating various cancer types. Transfer
RNA (tRNA) functions in deciphering the genetic code in mRNAs via codon-anticodon interactions and is one of
the most heavily modified RNA species in cells. The diverse and numerous chemical modifications of the
anticodon and main body of tRNAs are critical for tRNA integrity and function, thereby affecting protein synthesis.
This project will provide major new insight into the role of tRNA modification reprograming and translational
remodeling in cancer and cellular stress responses. RNA mass spectrometry and sequencing approaches will
be used to comprehensively catalogue tRNA modification and expression dynamics during melanoma
progression and metastasis using both human patient-derived xenografts and clinical samples. An innovative
new methodology for enhanced Ribosome profiling will be deployed to correlate RNA modification changes with
cancer-associated translational remodeling at codon resolution. Functional screening of all >600 human tRNA
genes will be performed to identify individual tRNA genes involved in various stress response pathways in cancer
cells, as well as tumorigenesis and metastasis in vivo. The role of several tRNA-modifying enzymes and
individual tRNAs in melanoma progression and stress response pathways will be investigated, and RNA mass
spectrometry, tRNA sequencing, Ribo-seq, and proteomic studies will be used to reveal the underlying molecular
and cellular mechanisms linked to cancer initiation, progression, and metastasis.

Public health relevance
Project Narrative More than 100,000 new cases of melanoma will be diagnosed in the USA this year and the 5-year survival rate is only 35% when it spreads to distant organs. Therefore, a better understanding of mechanisms of melanoma metastasis is therefore urgently needed. We will investigate the role of tRNA modifications and tRNA-modifying enzymes in the context of melanoma and metastasis.